Design, Synthesis and Efficacy of New Small Molecule Therapeutics to Impede Myotonic Dystrophy

Project Abstract
Myotonic dystrophy type 1 (DM1) is the leading cause of adult-onset muscular dystrophy, yet no effective
treatment strategies are available to DM1 patients. The parental grant to this supplement project is aimed at
understanding the disease mechanisms of myotonic dystrophy type 1 (DM1) and identifying potential therapeutics
for this multisystemic disease. DM1 is caused by a CTG expansion repeat in the 3’ untranslated region (UTR) of
the dystrophia myotonica protein kinase (DMPK) gene. When transcribed, the expanded repeats sequester
muscleblind-like (MBNL) proteins, a family of alternative splicing regulators, disrupting their normal cellular
splicing function. Our group has previously identified existing small molecules that rescue the molecular
hallmarks of DM1, such as correction of aberrant splicing and reduction of ribonuclear foci and have now
designed a series of new modified polycyclic compounds (MPCs) for evaluation. While we are currently
investigating the therapeutic potential and mechanism of action of these new MPCs, preliminary data suggests
that they operate through either reduction of the transcription of the toxic RNA and/or increases the expression
of MBNL proteins. The project for this supplement is focused on complementary studies that seek to better
understand the interaction between MBNL proteins, CUG expansion RNAs, and genome-wide splicing targets
through the generation, analysis, and evaluation of various synthetic MBNL proteins. The Berglund lab has
previous generated several synthetic MBNL proteins and demonstrated that these proteins show improved or
altered splicing activity. These data suggested that synthetic MBNL may have the potential to be used as tools for
investigating splicing regulation as well as for protein therapeutics for DM. Brianna’s project will extend and
leverage these studies by generating additional synthetic MBNL proteins and probing their structure and function
through in vitro biochemical assays and their impact on the RNA GOF in DM1 through transcriptomic studies in
cell culture. This one-year post-baccalaureate project will provide research and career development skills around
a central research project aim at: (1) identifying and characterizing in vitro the target engagement specificity of
engineered synthetic MBNL in the context of myotonic dystrophy type 1 expansion RNAs; and (2) determining
the in vivo transcriptomic specificity and therapeutic potential of engineered synthetic MBNL in DM1 patient-
derived cell lines. Determining the functional and global transcriptomic impacts of synthetic MBNL proteins will
enhance our understanding of the disease biology of DM while provide critical information to improve their
therapeutic potential for the treatment of DM1 and potentially other splicing-related repeat expansion diseases.

Public health relevance
Project Narrative Myotonic dystrophy (DM) is a member of a large 50+ family of repeat expansions disorders with a complex disease mechanism and no current treatment options. The muscleblind-like (MBNL) family of proteins play a critical disease role as these proteins as sequestered by the expansion RNA resulting in significant disruption of alternative splicing and other cellular processes. This one-year post-baccalaureate project will provide research and career development skills around a central research project that focuses on characterizing the impacts of synthetic engineer RNA-binding proteins on the complex disease mechanism of DM and as potential therapeutic approach to this devastating disease.